Metabolism and Malrotation

Project Summary/Abstract
Intestinal malrotation (IM) is a highly prevalent birth defect that can lead to life-threatening conditions
necessitating surgical intervention and long-term supplemental nutrition. Atrazine (ATR), a ubiquitous herbicide
that perturbs electron transport chain (ETC) reactions, was found to cause IM at high frequency. Preliminary
data show that ATR decreases mitochondrial respiration (i.e., oxidative phosphorylation; oxphos) and increases
glycolytic activity in the developing intestine. However, while early gut development can subsist on glycolysis
alone, later gut development requires oxphos; thus, ATR may block a critical metabolic switch from glycolysis to
mitochondrial respiration (oxphos) during intestine morphogenesis.
During normal gut development, intestinal rotation occurs simultaneously with gut lengthening, and
shorter gut lengths are often associated with IM, suggesting that gut elongation mechanisms are integral to the
rotation process. Indeed, cellular analyses reveal that ATR perturbs crucial events required to drive intestinal
lengthening, including early mesenchymal-to-epithelial transitions (MET) and, later, interkinetic nuclear migration
(IKNM) -- common morphogenetic processes recently found to be influenced by cellular metabolic states.
Together, these data suggest that a metabolic switch from glycolysis to oxphos drives proper
intestine rotation by regulating the timing and/or localization of MET and IKNM events during gut
elongation. This hypothesis will be tested using innovative metabolomics technologies to determine: 1) how
ATR affects the spatiotemporal dynamics of cellular metabolism during intestine morphogenesis, and 2) how
dynamic cellular metabolic states affect the timing and localization of MET and IKNM within the developing
intestine. Successful completion of these aims will illuminate the poorly understood etiology of IM, and will have
implications for the role of metabolism-altering toxins, diseases, and/or pregnancy conditions in the development
of structural birth defects that depend on MET- and/or IKNM-mediated morphogenesis.

Public health relevance
Project Narrative This project investigates how fundamental metabolic processes (i.e., glycolysis and mitochondrial respiration) regulate the cellular events that drive the elongation and rotation of the embryonic digestive tract. The results will provide new insight into the etiology of intestinal malrotation, a common birth defect with significant morbidity. Moreover, as the morphogenetic mechanisms regulated by metabolism -- mesenchymal- to-epithelial transitions and interkinetic nuclear migration --underlie the proper formation of many tissues and organs throughout the embryo, the findings will also reveal how abnormal maternal or fetal metabolism could contribute to a wide variety of structural birth defects.